Elucidating structural and functional mechanisms of pyroptosis

Summary
Pyroptosis is a most “explosive” and immunogenic form of lytic cell death involving spillage of
cellular contents, and has been defined as cell death mediated by the gasdermin (GSDM) family
of proteins. This breakthrough understanding was brought about in 2015 when gasdermin D
(GSDMD) was identified as a downstream effector of inflammasomes, which are supramolecular
complexes that activate inflammatory caspases (-1, -4 and -5 in human and -1 and -11 in mouse).
GSDMD gets cleaved by caspases to generate an N-terminal fragment (GSDMD-NT) and a C-
terminal fragment (GSDMD-CT), and GSDMD-NT was shown to mediate pyroptosis, as well as
the release of IL-1 family cytokines, which are processed by caspase-1 to the mature form. The
GSDM family comprises six members in humans (GSDMA, GSDMB, GSDMC, GSDMD,
GSDME/DFNA5, and DFNB59). In 2021, Ninjurin1 (NINJ1), a member of the NINJ family
comprised of 2 transmembrane proteins in mammals, was shown to act downstream of GSDMD
pore formation to induce the plasma membrane rupture required for full release of damage-
associated molecular patterns (DAMP) such as lactate dehydrogenase (LDH).
We and others found that upon cleavage by inflammatory caspases, GSDMD-NT specifically
binds to acidic lipids, and exhibits strong membrane-disrupting cytotoxicity in mammalian cells by
forming pores on membranes during pyroptosis and in vitro. Other GSDMs, upon cleavage by
appropriate proteases, also form transmembrane pores.
Here we propose to elucidate the structural mechanism of pore formation by the GSDM family,
and of membrane disruption by NINJ1. Understanding how GSDMs are regulated and exert their
pore forming activity, and how NINJ1 oligomerizes to induce plasma membrane rupture will not
only provide new insights on pyroptosis, but also afford new therapeutic strategies for treating
inflammasome-related and pyroptosis-related diseases.

Public health relevance
Narrative GSDMs and NINJ1 are associated with many human diseases, and deletion of GSDMD or NINJ1 significantly decreases pyroptosis, and remarkably protects mice from sepsis. Genetic mutations in GSDMA3, GSDME or DFNB59 cause alopecia and hyperkeratosis in mice and nonsyndromic hearing loss in humans, while polymorphism of GSDMB is linked to increased asthma and IBD risk. Elucidating the structural mechanism of pore formation by GSDMs will have significant impact on generating potential therapeutics against these diseases.